Regulation of epidermal homeostasis by centrosomal proteins

PROJECT SUMMARY
This proposal describes a five-year training program to support the development of an academic, physician-
scientist with a focus on advancing the understanding of cutaneous inflammatory diseases. The principal
investigator has a strong track record of basic science research in the areas of molecular virology, immunology,
and cell biology and seeks to enhance her expertise in centrosome, cytoskeletal, and keratinocyte biology.
Central to her further training is a proposed mentored research project focusing on the role of centrosomal protein
CEP43 in the maintenance of epidermal integrity and its link to immune activation. Keratinocytes prevent
epidermal disruption and promote epidermal homeostasis by the formation of a highly organized network
supported by specialized cell junctions and adhesion molecules that are supported by the cytoskeleton and
organized by the centrosome. The PI presents preliminary data showing that targeted deletion of Cep43 in the
epidermis leads to dysregulation of the keratinocyte cytoskeleton and robust psoriasiform rash. These data
strongly suggest that the research plan will define new mechanisms linking keratinocyte and epidermal integrity
to immune activation by focusing on the centrosome and the centrosomal protein CEP43 in particular, and that
this approach will ultimately lead to the identification of novel pathways contributing to epidermal homeostasis
that could serve as therapeutic targets for the treatment of inflammatory skin disease. The specific aims are: (1)
Define mechanisms by which CEP43 loss leads to keratinocyte stress and p53 activation, (2) Define mechanisms
by which CEP43 loss leads to inflammation and psoriasiform dermatitis. The research design employs cutting-
edge techniques and novel animal models. Ultra-expansion microscopy (UExM) will be used for super-resolution
imaging of centrosomal and cytoskeletal structures in keratinocytes. Newly created conditional knockout mice
enable Cep43 deletion specifically in keratinocytes, followed by phenotypic analyses using histology,
transmission electron microscopy, and transcriptomic profiling to assess cellular stress responses and
inflammatory pathways. The candidate’s career development plan includes hands-on training in UExM and
participation in leadership, mentorship, and grant-writing workshops. Regular mentorship meetings with Dr.
Marco Colonna, a world expert in innate immunity, and Dr. Moe R. Mahjoub, a leader in centrosomal and
cytoskeletal biology, will provide robust guidance. Washington University in St. Louis provides a supportive
environment with state-of-the-art facilities, a collaborative research community, and guaranteed protected
research time. This environment, combined with strong mentorship and advanced resources, will enable the
candidate to successfully transition to an independent investigator and significantly advance our understanding
of cutaneous inflammatory diseases.

Public health relevance
PROJECT NARRATIVE Keratinocytes are key first-line elements of the immune system with the ability to sense and respond to perturbation. This proposal seeks to define the mechanisms by which keratinocyte stress leads to immune activation by focusing on the centrosome. Understanding these mechanisms has the potential to identify novel pathways contributing to epidermal homeostasis that could serve as therapeutic targets for the treatment of inflammatory skin diseases unresponsive to currently available therapies.